Administrative Core

PROJECT SUMMARY
The Cleveland Alzheimer's Disease Research Center (CADRC) is a collaborative effort of investigators
at five Cleveland area institutions: Case Western Reserve University (CWRU), Cleveland Clinic Foundation
(CCF), MetroHealth Systems (MHS), University Hospitals (UH), and the Louis Stokes Cleveland Veterans
Affairs Medical Center (LSCVAMC). The Administrative Core (AC) of the CADRC has the overall responsibility
for promoting the successful integration of the participating sites and investigators and the successful
completion of the Center's goals. The AC works closely with the other cores to achieve the aims of the CADRC
and milestones of the National Alzheimer's Project Act. In addition, the AC has a unique role in the CADRC of
promoting close collaboration between CADRC investigators, Cores, local neurodegeneration research
investigators, and local community leaders to foster an active center of Alzheimer's disease (AD) and AD-
related dementias (ADRD).The AC has primary responsibility for coordinating and leading CADRC group
activities including weekly AC/administrator meetings, monthly Core leaders meeting, the twice yearly Internal
Advisory Committee (IAC) meetings, and annual External Advisory Committee (EAC) visits. These meetings
review the activities and accomplishments of the cores, ensures timely transmission of CADRC data and
biospecimens to the National Alzheimer's Coordinating Center (NACC) and National Centralized Repository for
Alzheimer's Disease and Related Dementias (NCRAD), and fosters additional collaborations between cores
(Specific Aim 1). The AC also provides external support and advice to the CADRC investigators on advancing
the goals and aims of the center (Specific Aim 2) and promotes interactions with other Alzheimer Disease
Research Centers, collaborations and opportunities for additional funding (Specific Aim 4). The AC provides
compliance oversight and obtains/renews centralized institutional review board approval of CADRC activities
(Specific Aim 3). Lastly, the AC oversees and promotes training and support to students, fellows, and junior
faculty through the establishment of an annual Development Project Grant Program (Specific Aim 5).